Modulating cortical inhibitory networks to facilitate stroke recovery

PROJECT SUMMARY/ABSTRACT
The overarching goal of this project is to identify new targets for neural circuit modulation to facilitate motor
recovery after stroke. To accomplish this, I propose to identify how dynamics in a specific inhibitory cell network
participates in motor learning, investigate how these dynamics are disrupted by stroke, and test whether their
modulation can improve recovery. Completion of this project will provide me with opportunities to fill key gaps in
my current skillset and equip me to launch an independent research program in the neurophysiology of recovery.
I have carefully designed a career development program to address these training gaps through a combination
of hands-on experimentation, coursework and didactics, and mentorship from an exemplary team of physician
scientists at UCSF. My mentorship team has a strong record of training and developing young investigators;
together with the rich research environment at UCSF, I will be well-equipped to accomplish all of my outlined
training goals. The results from these experiments will lead to publications, culminate in an R01 application, and
pave the way for many important lines of investigation I will pursue in my own laboratory.

Public health relevance
PROJECT NARRATIVE Neuromodulation is a promising treatment avenue for enhancing recovery from stroke, but current approaches are limited by a limited understanding for how external stimulation interacts with brain dynamics. Here, I propose to (1) study how dynamics in a specific inhibitory network supports motor learning and recovery and (2) probe the impact of activating these inhibitory networks on learning and recovery. My goal is to discover fundamental principles for neural circuit plasticity that can be translated into more effective neuromodulation therapies for stroke patients.